High-dose Vitamin D Supplementation for ADT-Induced Bone Loss in Older Prostate Cancer Patients

ABSTRACT:
Use of androgen deprivation therapy (ADT), which causes near-total loss of testosterone, has increased
dramatically in elderly prostate cancer patients over the last decade. ADT is associated with a significant increase
in bone mineral density (BMD) loss (2-5% annually) and bone fractures, combined with a significant decrease in
skeletal muscle mass (2-5% annually) compared to age-matched prostate cancer patients not on ADT and men
without cancer. The loss of BMD and muscle mass results in a high prevalence of falls, reduced muscular
strength, and decreased balance. Despite the high incidence of ADT-related side effects, treatment options are
limited. Bisphosphonate therapy is commonly used for ADT-induced bone loss, but is associated with significant
side effects and poor compliance. Vitamin D protects against BMD loss and fractures, but its effects are strongly
dose-dependent. Current IOM recommended supplementation (600-800 IU/day) and serum 25-OH levels (20
ng/mL) are inadequate to protect against bone loss in a high risk population such as prostate cancer patients on
ADT. In addition, RCT interventions of 400-500 IU/day of vitamin D fail to prevent ADT-induced bone loss. High-
dose vitamin D supplementation (e.g., 50,000 IU/week) is a promising intervention that significantly increases
25-OH vitamin D to levels shown to improve BMD in other populations. Vitamin D has also been shown to
increase muscular strength, reduce falls, and improve balance. In preparation for this R01, we conducted a
Phase II randomized controlled trial (RCT) investigating the feasibility, safety, and preliminary efficacy of HDVD
versus placebo for 24 weeks in 59 prostate cancer patients receiving ADT (NCI R21CA185678; PI: Peppone).
Compelling evidence from our pilot study showed: 1) 50,000 IU/week of vitamin D (HDVD) was safe with no
increase in toxicity versus low-dose vitamin D, 2) compliance was excellent at 94%, and 3) HDVD significantly
increased 25-OH vitamin D levels. Those randomized to HDVD lost 1.9% BMD at the total hip versus 3.7% loss
in the placebo group (p=0.03). Stratified analyses showed the HDVD group lost 2.3% BMD at the total hip vs
7.1% for the placebo group for those with baseline vitamin D <27 ng/ml (p<0.01). Based on our preliminary data,
we propose to conduct a definitive, multi-center, phase III RCT in which 366 prostate cancer patients ≥65 years
old starting ADT with vitamin D <27 ng/ml will be randomized to 1) 50,000 IU/week vitamin D or 2) a matching
placebo for 52 weeks. All participants will receive a daily supplementation (800 IU vitamin D/1,000 mg calcium)
to ensure a minimum of 100% RDA. The primary outcomes is the change in BMD, while secondary outcomes
include changes in the clinically relevant outcomes of falls, balance, quality of life and fractures. We also plan to
explore the biological pathways of ADT-induced bone loss and response to HDVD using bone biomarkers. If
found to be efficacious, HDVD would be a safe, low-cost, widely-available OTC treatment that could revolutionize
management of ADT-induced bone loss and change clinical practice paradigms.

Public health relevance
PROJECT NARRATIVE Use of androgen deprivation therapy (ADT), which causes near-total loss of testosterone, has increased dramatically in elderly prostate cancer patients over the last decade. ADT is associated with a 2% to 5% loss of bone mineral density, which is accompanied by significant increases in falls, fractures, and sarcopenia with significant decreases in balance and muscle strength compared to prostate cancer patients not on ADT and age- matched men without cancer. High-dose vitamin D is a promising intervention that may prevent these ADT- related consequences; if found to be efficacious, it would be a safe, low-cost, widely available, non- pharmacologic treatment that could drastically improve the prevention of ADT-induced bone loss and change clinical practice paradigms.